Michigan Nutrition Obesity Research Center

– P and F Program
The primary goal of the MNORC Pilot and Feasibility Grants Program (P and F) is to promote research on the biological and behavioral determinants of obesity, the effects of altered composition and quantity of nutrients to alter metabolism and modulate disease risk, and to develop interventions to reduce obesity and its disease sequelae using basic, clinical, or population approaches. To achieve this goal, we provide opportunities for both new and established University of Michigan investigators to generate sufficient preliminary information for a successful application for major research funding from NIH or other national granting agencies. The $100k/year for the MNORC P and F grant program is funded from cost-sharing provided by several departments/schools within the University of Michigan and is currently in the midst of its third cycle of funding. Two to three standard pilot grants have been given out each year. Grants given to junior faculty and trainees have additionally had mentors assigned to ensure progress of the projects. This financial and career investment has resulted in a considerable return of published papers, funded NIH grants, career advancement, and collaborations with other MNORC members.

Public health relevance
Narrative Obesity and poor diets are major contributors to a wide range of health problems, increased healthcare costs and reduced quality of life. The Michigan Nutrition Obesity Research Center will provide researchers the opportunity to utilize advanced technologies and computational tools to understand how obesity and diet vary both among individuals and across the population. Together these efforts can inform health professionals’ strategies to design and implement novel dietary, physical activity, and medical interventions to prevent and manage obesity and improve nutrition in both adults and children.